Acid Sphingomyelinase Inhibition to Mitigate the Environmental Exposure Risks of Ultraviolet Light-Induced Actinic Neoplasia and Squamous Cell Carcinoma in US Veterans

PROJECT SUMMARY
Actinic neoplasia (precancerous actinic keratosis [AK] and non-melanoma skin cancer) is the most common
type of human neoplasia, and the most common diagnosis in VA dermatology clinics. The high incidence of
actinic neoplasia amongst our veterans is not surprising as most served in areas with considerable ultraviolet
(UV) light exposure. Indeed, UV light is a ubiquitous environmental exposure for our service members,
especially during wartime deployments. Hence, studies to improve the treatment of our veterans with multiple
AK will be impactful in our veteran patients. Our research group has a long track record of successful
investigations in the mechanisms by which aging and ultraviolet B radiation (UVB) contribute to actinic
neoplasia, as well as how stressors such as UVB and the AK treatment photodynamic therapy (PDT) interact
with skin. Our group has recently discovered that PDT, like UVB, can generate subcellular microvesicle
particles (MVP) in keratinocytes and human/murine skin. Of importance, pharmacologic and genetic
approaches neutralizing the key MVP-generating enzyme acid sphingomyelinase (aSMase) has revealed that
PDT-induced immunosuppression is dependent upon MVP. Since PDT-induced immunosuppression is an
unwanted side effect of PDT that limits its effectiveness in treating precancerous AK, blocking aSMase should
significantly improve the effectiveness of PDT. PDT has a number of advantages over the other secondary
prevention strategies that we utilize to prevent skin cancers in our veterans. To that end, this new MERP
proposal will test the hypothesis that treatment of human subjects undergoing PDT with topical aSMase
inhibitor imipramine will increase the effectiveness of this therapy. Moreover, characterization of the contents
of PDT-generated MVP will allow an enhanced understanding of their biologic effects. Aim 1 will consist of a
double-blinded placebo-controlled clinical trial using split-sides of topical imipramine versus vehicle for patients
undergoing PDT for field treatment of multiple AKs to either face/scalp or forearms. The outcomes will consist
of testing effectiveness of left/right sided treatments on AK counts at 6 and 12 months (and likely much longer).
Moreover, we will employ a novel strategy using mesoscopic imaging that can discern and quantitate
subclinical actinic damage based upon light scattering characteristics. We will also test if topical imipramine
blocks PDT-induced immunosuppression by skin testing and tissue RNA-seq for subjects undergoing PDT to
forearms. As agents that inhibit aSMase such as imipramine also exhibit nociceptive qualities, these studies
will also assess if this intervention affects acute inflammation and pain/itch associated with PDT. Aim 2 will
consist of mechanistic studies to characterize the bioactive cytokine and lipid mediator contents of PDT-
generated MVP from human keratinocytes and human skin explants subjected to experimental PDT. PDT-
generated MVP will be compared to UVB- and phorbol ester-generated MVP which have distinct biologic &
immunologic effects. Since PDT as currently practiced for treating large areas of skin has limited effectiveness
and is associated with considerable pain, the current studies can provide a modification which could be highly
effective and increase the use of this potentially life-saving modality. These studies will improve the care of
veterans served in our dermatology clinics. Moreover, the successful employment of mesoscopic imaging will
further validate a valuable clinical tool that can stratify risk of actinic neoplasia even when skin appears
clinically normal. This non-invasive, image-based contrast mapping approach could serve to propel research in
field cancerization using skin as a model system, which could be adapted to other epithelial cancers relevant to
the veteran population such as colon, esophageal, and lung cancers. Finally, these studies can provide
important insights into the biological effects of subcellular microvesicle in the context of skin responses to
environmentally relevant stressors.

Public health relevance
PROJECT NARRATIVE Photodynamic therapy (PDT) is an FDA-approved “field” treatment for patients with multiple pre-cancerous skin lesions used to limit future skin cancers in veterans with environmental ultraviolet radiation exposure. In the management of VA patients with skin cancers, PDT is underutilized since it is very painful to the patient and PDT-induced immunosuppressive effects on skin inhibit its overall effectiveness. The overall goal of these studies is to define the role of subcellular particles as agents that block the effectiveness of topical PDT used to treat pre-cancerous sun-damaged skin. A double-blinded placebo-controlled clinical trial will test if an agent that blocks PDT-induced immunosuppression in mice can improve PDT effectiveness in human patients. Finally, mechanistic studies will characterize exact contents of the subcellular particles. If successful, these studies will improve the effectiveness and tolerability of topical PDT. Since actinic neoplasia is the most common diagnosis in VA dermatology clinics, these studies will improve veterans care and save lives.